RARE and Atypical Diabetes Network(RADIANT)

ADMINISTRATIVE CORE – PROJECT SUMMARY/ABSTRACT
The Administrative Core is to further RADIANT goals by managing RADIANT resources and demonstrating
leadership to RADIANT committees and special interest groups. RADIANT has an administrative committee
structure and a scientific committee structure. Committee leadership, membership and overall responsibilities
are approved by the Steering Committee. Committee chairs are appointed for a minimum term of 1 year at
which point they will be reassessed by the Steering Committee to ensure committee objectives and goals are
being reached. Administrative committees focus on protocol operations and are overseen by the Steering
Committee. The following are the administrative committees: Coordinators, Recruitment and Retention,
Protocol Oversight (previously Protocol Implementation), and Laboratory Implementation. Scientific committees
are focused on the identification of rare and atypical forms of diabetes (Adjudication Committee, Discovery
Team, Publications and Presentations), Ancillary Studies/Data Access, and the analysis of accumulating data
(Special Interest Groups (SIG)) to ensure comprehensive oversight of study outcomes, additional scientific
discovery (e.g., deeper phenotyping) and data analysis. 14 SIGs have been established thus far to focus on
next steps for phenotypic cohorts, cases with promising genetic variants, and genome exploration. The
Administrative Core also oversees the design and implementation of the RADIANT website. The RADIANT
DCC continues to expand and implement the RADIANT platform, an enterprise level web-based portal for the
RADIANT network which provides applications and services that enables users to identify, screen, enroll, and
collect data from individuals with atypical diabetes, as well as store, manage, analyze, and share those
data. The system also includes applications for specimen collection, tracking, laboratory results and analysis,
adverse events tracking, reporting, data compliance, and study staff and committee communications and
collaboration.